Project 2 - McNally (NU)_Spencer (UCLA)

Abstract
Although there has been progress in human gene therapy for muscular dystrophy, multiple issues have arisen
during the clinical trials that necessitate developing improved safety and efficacy. Human AAV clinical trials for
Limb girdle muscular dystrophy (LGMD) have initiated for β-sarcoglycan- and FKRP-related LGMDs. Like
Duchenne muscular dystrophy, for these LGMD subtypes there is a need to correct both skeletal and cardiac
muscle since these forms of LGMD are also associated with cardiomyopathy. We developed the first
genetically engineered mouse model of LGMD and conducted early proof-of-principle studies of viral gene
replacement, demonstrating restoration of sarcoglycan components within the dystrophin complex. Gamma
sarcoglycan is encoded by the SGCG gene and is an ideal small cargo for AAV therapy, since the promoter
and entire coding region fit well within AAV carrying capacity, unlike micro-dystrophin which only
accommodates 30% of the full-length dystrophin protein. LGMD due to gamma sarcoglycan mutations and
DMD share a similar clinical timeline with skeletal muscle and cardiac muscle involvement. Therefore,
investigating and comparing results between gene therapy for these two diseases should inform clinically
relevant issues related to functional rescue for skeletal muscle and the heart. The human clinical trial
experience with micro-dystrophin has acutely identified the need to better define immune responses to AAV
vectors and to develop animal models that better predict human immune responses. Immune responses can
arise to the capsid, viral genome, or expressed protein cargo, leading to liver toxicity and limiting transgene
durability. Newer, myotropic vectors are expected to improve safety by having less liver targeting and the
ability to deliver effective therapy at lower doses. Additionally, codon-optimized vectors need to consider the
presence of unmethylated CpGs that can unintentionally trigger adverse Toll Like Receptor (TLR) activity which
has been associated with liver toxicity. In Aim 1, we will test TLR stimulatory activity of AAV vectors in human
THP1 cells and combine optimized coding sequences with myotropic AAVs to improve striated muscle
transduction and reduce immune response by testing in mouse models and human engineered heart tissues
and monitoring for adverse outcomes. In Aim 2, we will test efficacy of these AAVs in an LGMD preclinical
model, determining minimal and maximally efficacious doses and correlating with functional rescue. In Aim 3
we will further optimize and apply a dual dosing strategy to create better models of human immune response to
AAV for treating muscle disease.